AIDS Malignancy Consortium (AMC)

PROJECT SUMMARY/ABSTRACT
The AIDS Malignancy Consortium (AMC) was established in 1995 and has been at the forefront
of the clinical evaluation of interventions for the treatment and prevention of malignancies in
people living with the human immunodeficiency virus (PLWH). AMC also studies the biology of
cancers and precancerous lesions in PLWH in the context of its clinical trials, providing new
insights on further improving the treatment and prevention of cancer. The AMC has conducted
over 100 clinical trials, surveys and laboratory studies involving over 8700 patients with HIV-
associated cancers and precancerous lesions since its inception, including application of
precision therapeutics and immunotherapy, impacting the standard of care for PLWH and
cancer. AMC has established a network of 42 core clinical trial sites in the United States, Africa,
and Latin America uniquely qualified carry out its mission, created a network of translational
scientists and their research laboratories that support AMC clinical trials, and developed a
career enhancement program that has fostered a new generation of physicians and scientists
with unique expertise in HIV-associated cancers. Expansion of AMC to clinical trials sites in sub-
Saharan Africa and Latin America is designed to address regions of the world where the
epidemic of HIV and cancer has grown substantially, thereby amplifying the potential clinical
impact of its work to a global scale. AMC has also actively engaged PLWH and cancer survivors
in its scientific planning and community outreach in order to identify the needs of the community,
and disseminate information about AMC and its completed and ongoing research. The
participation of many of the key clinicians and clinical researchers, laboratory scientists, and
community representatives has made AMC the principal clinical trials group in the world
dedicated to improving the treatment and prevention of cancers in this population. We propose
to continue and expand our domestic and international clinical trials work in these areas,
including the ANCHOR trial; ANCHOR is a large randomized study investigating the role of
routine screening for and treatment of high-grade anal squamous intraepithelial lesions, with the
goal of preventing development of invasive anal cancer and the morbidity and mortality
associated with its diagnosis and treatment, thereby establishing new diagnostic and
therapeutic paradigm.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Cancer has been recognized as occurring more commonly in people living with human immunodeficiency virus infection (PLWH), and remains a leading cause of morbidity and mortality despite improvements in antiretroviral therapy. The spectrum of these cancers in PLWH is diverse, complex, and challenging to prevent and treat. AMC remains the only organization worldwide solely dedicated to the study, treatment and prevention of cancer in PLWH.